Heat-related illness and farmworker’s health: Climate change and precarious employment

ABSTRACT
The Michigan Lifestage Environmental Exposures and Disease (M-LEEaD) Core Center (P30), funded by the
National Institute of Environmental Health Sciences (NIEHS), is based at the University of Michigan and is
organized around the theme of critical windows of susceptibility to environmental exposures as important
determinants of disease. Its mission is to accelerate research that defines impacts of environmental exposures
during vulnerable stages of life, and to translate those findings to improve medical and public health
interventions. The goal of this diversity supplement to M-LEEaD is to conduct epidemiological research
to study the impact of heat related illness (HRI) on the health of farmworkers. Extreme heat events are
increasing in the United States (US) in frequency, intensity, and duration. Analysis from a 15 year period
(1992-2006) showed that the heat-related average annual death rate for agricultural crop workers was 0.39 per
100,000 workers, compared with 0.02 for the US civilian population. As climate change causes temperatures to
continue to rise, heat waves are expected to become more frequent and severe in the coming decades. This is
a public health concern for US farmworkers—primarily Latinos(as) working under precarious working
conditions and impacted by a wide range of chronic diseases, social and economic factors that may
exacerbate their vulnerability to heat-related illnesses. Precarious employment for farmworkers--and the
resulting inequitably distributed environmental exposures—is a key social determinant of health with
implications for environmental justice. Our specific aims are: (1) To examine cross-sectional associations of
employment-based risk factors for HRI and cardiovascular disease using qualitative data from the Michigan
Farmworker project and conducting a systematic literature review to identify employment-based risk factors for
HRI and health. Then, quantitative analysis will be conducted using data from the National Agricultural Worker
Survey (NAWS 1999-2018) to assess its association with self-reported data on cardiovascular risk factors
(hypertension and diabetes) collected in NAWS, (2) To assess nationwide trend analysis in fatality rates due to
HRI in farmworkers (1992 – 2020) using data from the Bureau of Labor Statistics Census of Fatal Occupational
Injuries (CFOI) and data on heat-related deaths identified in the CFOI as an exposure and calculate fatality
rates among farmworkers nationwide. Using national and publicly available meteorological data, we will assess
the correlation of heat waves with fatalities in farmworkers during the same time-period, (3) To develop
dissemination materials for farmworkers based on findings in Aim 1 and 2 by using “policy briefs” in English
and Spanish through a social media platform that provides accessible scientific information in environmental
health and justice in the context of the findings of the proposed study. The proposed supplement is aligned
with the mission of the M-LEEaD center with the central goal to further scientific knowledge on the
environmental and occupational health impact of precarious employment in farmworkers.

Public health relevance
Public Health Relevance Climate change and the increased frequency, intensity and duration of heat waves are threats to the health and wellbeing of farmworkers, essential workers who contribute to feeding the nation. This largely Latino workforce experiences a range of precarious work conditions. The study will research farmworkers’ chronic disease and how heat related illness and precarious working conditions contribute to their health, and will inform and guide efforts to enhance health equity and environmental justice in a critically important and vulnerable population.